A RANDOMIZED CLINICAL TRIAL OF UMBILICAL ARTERY CATHETER PLACEMENT

This project was formulated to determine if very low birth weight infants who receive umbilical artery catheters that are placed high in the thoracic aorta (T6-T8) are at higher risk of intraventricular hemorrhage than are infants that receive an umbilical artery catheter placed low in the abdominal aorta (L4-L5). We are presently randomizing infants to receive either a high or low catheter and then determining the incidence of intraventricular hemorrhage. The project is scheduled to enroll a total of 700 infants in 12 neonatal intensive care units. A contract for a Data Coordinating Center has been awarded to Scientific Applications Co. To date approximately 500 infants have been enrolled in the protocol. Enrollment should be completed by October.